Understanding Social Determinants of Health and Health Disparities in Emerging Work Contexts

PROJECT SUMMARY
Working-aged American adults spend large portions of their days engaged in work—a major social determinant
of health. The growth of non-standard work arrangements in the United States has had detrimental impacts on
the health and well-being of workers. These evolving arrangements are defined as Emergent Work (EW), or
contemporary work that is outside of traditional full-time employment, expected to end, lacking an implicit or
explicit contract, and/or precarious. Because minoritized workers disproportionately comprise workers in EW,
the national trend towards EW may also exacerbate health disparities. Developing a nuanced understanding of
EW and its relationship to health, well-being, and health disparities is essential for improving population health
in the United States. Toward this end, this project includes a comprehensive training plan and integrative
investigation of EW in California, a state at the forefront of this labor market trend. The project PI is a postdoctoral
research associate in the University of Southern California’s Chan Division of Occupational Science and
Occupational Therapy. The PI will work with a mentorship team of worker health and methods experts to
complete a multi-method study of the state-wide California Work and Health Survey, a comprehensive study of
work and health factors in 4,104 workers from the California labor force. Aim 1 will identify latent classes of EW
among workers aligned with contemporary work arrangements. Aim 2 will characterize contemporary EW based
on worker demographics, health, and well-being. Aim 3 will examine workers’ lived experiences of participation
in EW relative to health and well-being. Completing these scientific aims will contribute to a comprehensive
understanding of objective and subjective factors influencing health and well-being in EW and provide insight
into personal factors informing the relationships between EW and potential health disparities. Concurrent didactic,
project-based, and professional development activities will complement mentorship and pursuit of these three
aims. Specifically, training in data science and survey analysis methods will support the completion of Aims 1
and 2, and instruction in qualitative methods will support the completion of Aim 3. Coursework will be completed
to advance understanding of work as a social determinant of health and research methods, and efforts will be
directed toward professional development and dissemination. These integrative experiences with a mentored
research project and a comprehensive training plan will launch the PI’s career as a junior scientist interested in
understanding social determinants of health in workers and addressing worker health disparities. This project
aligns with the National Institute on Minority Health and Health Disparity’s research concept about the role of
work in health disparities in the United States, as well as the Healthy People 2030 initiative’s focus on the work
and the workplace as community-level social determinants of health.

Public health relevance
PROJECT NARRATIVE Work is a social determinant of health, and workers in the United States increasingly engage in non-standard work arrangements that may be classified as forms of emergent work. To better understand emergent work’s implications for worker health and well-being, this project will investigate how these non-standard work arrangements can be classified into distinct forms of emergent work and the lived experiences of emergent work relative to health, well-being, and health disparities. This project will enhance understanding of objective and subjective factors influencing the health and well-being of contemporary workers.